Progenitor cell based therapy to mitigate radiation induced gastro intestinal syndrome- supplement

Project Summary:
Currently, there is a need for strategies that mitigate acute radiation-induced gastrointestinal syndrome (RIGS).
The risk of large populations including children encountering radiation exposure is real and growing. Although
some studies have been performed in development of MCM targeting adult population almost no information is
available for pediatric population. Unavailability of a suitable pediatric models further limits any progress on
development of MCM for children. The high radiosensitivity of the intestinal epithelium increases susceptibility
to RIGS; and with mortality within 10-15 days there is limited time for therapeutic intervention. We have
developed a human myeloid committed progenitor (MCP) cell therapy which can mitigate RIGS and improve
survival when applied 24 hr after an otherwise lethal dose of radiation exposure. These progenitor cells are
modulated ex-vivo to increase expression of WNT ligand, a major paracrine signal for intestinal epithelial
regeneration. In this project we will fully characterize RIGS using pediatric rodent model. Finally we will
evaluate the involvement of MCP derived WNT signaling in repair and regeneration of intestinal stem cells in
this model.

Public health relevance
Project Narrative: The proposed research will characterize radiation induced gastrointestinal injury in pediatric mice and ex-vivo human intestinal organoid from pediatric tissue. Cell therapy as a radiation countermeasure against radiation injury will be examined in pediatric radiation injury model. Successful completion of this project will lead to the development of this cell therapy as a new medical countermeasure to treat injuries resulting from a radiation or nuclear accident.